Slow Wave Induction by Propofol to Eliminate Depression (SWIPED) Trial

ABSTRACT
Treatment Resistant Depression (TRD) in older adults is a leading cause of disability, excess mortality from
suicide, and dementia. Cognitive problems and sleep disturbances are common, contributing to recurrence and
poor long-term outcomes. Disrupted slow wave sleep is at the nexus of depression and cognitive dysfunction in
older adults. Novel approaches to target this core pathophysiology are lacking. Our mechanistic project,
Slow Wave Induction by Propofol to Eliminate Depression (SWIPED) Trial, is designed to elucidate the
relationships between TRD, sleep disturbances, and cognitive impairments in older adults. Through personalized
infusions targeting electroencephalographic (EEG) patterns, we aim for a systematic characterization of the
relationships between the propofol-induced EEG slow waves, enhancement of slow wave sleep, and cognitive
outcomes. Through the repurposing of propofol, this innovative proposal will establish whether EEG slow waves
are a viable therapeutic target for novel antidepressant approaches. The project consists of two clinical trials
(Phase 1 and Phase 2) in older adults with TRD. In Phase 1 we will enroll 15 individuals to receive a dose-finding
propofol infusion, and then a second infusion at the dose determined to induce slow waves. This phase will
establish that propofol both induces slow waves during the infusion and enhances slow wave sleep (SWS) on
nights of sleep post-infusion. Then, in Phase 2 we will randomize 60 individuals to multiple infusions of propofol
at either a dose that induces slow waves, or a subthreshold dose that does not induce slow waves, and we will
examine short and long-term changes in post-infusion SWS as well as executive function, alertness, and
depressive symptoms. This phase will test whether enhancement of SWS leads to improvements in cognitive
function and mood. This work will enhance our understanding of core deficits contributing to poor mood and
cognition in a population at risk for Alzheimer's disease and related dementias. With the rise in the aging
population, we hope to provide translatable biomarkers and approaches for future precision medicine, with a
long-term goal of improving public health and quality of life for those afflicted with TRD.

Public health relevance
PROJECT NARRATIVE Treatment resistant depression (TRD) in older adults is a leading cause of disability, dementia, and poor quality of life. Deficient slow waves sleep is at the nexus of depression and cognitive dysfunction in older adults, but novel treatments have not targeted this core pathophysiology. These combined Phase 1 and Phase 2 mechanistic clinical trials will investigate whether propofol confers slow wave sleep enhancement, resulting in longer-term improvements to sleep structure, cognitive function, and mood.